Expanding the Observer-Reported Communication Ability (ORCA) Measure: Measuring the communication ability of individuals with rare, neurodevelopmental disorders

PROJECT SUMMARY / ABSTRACT:
Children with neurodevelopmental disorders (NDDs) typically have severe deficits in domains of daily functioning
like communication, which families consistently list as one of their top clinical priorities. However, existing clinical
outcome assessments (COAs) have major limitations, including the inability to discriminate among individuals with
low communication ability and/or are primarily nonverbal. Further, there are no current caregiver-reported measures
designed for clinical trials that have high quality validity evidence for individuals with NDDs.
To address this critical need, our team designed the Observer-Reported Communication Ability (ORCA) measure to
assess expressive, receptive, and pragmatic forms of communication, regardless of the modalities used by a child
(e.g., vocalizations, gestures, assistive devices). Qualitative and quantitative evidence support its validity for
individuals with Angelman syndrome, and excitingly, the ORCA is likely to be generalizable to other NDD
populations. This proposed study will allow us to use rigorous development methods to expand the ORCA measure
to a broad range of NDD populations and, using existing COAs, provide investigators with a comprehensive set of
tools to evaluate changes in communication ability in NDD populations in pediatric clinical trials.
Our study team includes experts in COA development, communication, clinical trials, and neuropsychology.
Importantly, the team also includes a Stakeholder Engagement Group (SEG) consisting of 16 leaders in the field; 12
parents/patient advocates and 4 clinicians who will provide access to 13 distinct NDD populations for the studies
planned in this proposal. An External Technical Advisory Committee (ETAC) will provide additional guidance and
consists of clinicians, methodologists, speech-language pathologists, industry experts, and patient advocates.
In the 2-year UG3 planning phase, we will conduct qualitative interviews with 8-12 parents for each of our 13 NDDs
and with 8-12 communication experts to identify the core concepts of communication for each of the NDDs (Aim 1).
We will use the results from the qualitative interviews and data collected in seven ongoing natural history studies to
develop targeted plans for the UH3 implementation phase to expand and validate the ORCA measure for each of
the 13 NDDs (Aim 2). In the 3-year UH3 phase, we will expand the ORCA measure and conduct, as needed,
additional qualitative interviews and longitudinal quantitative studies to evaluate the reliability, validity and
responsiveness of the ORCA measure alongside other communication COAs (Aim 3). Finally, we will have
approximately 1500 caregivers of typically developing children from birth to <6 years of age complete the expanded
ORCA measure twice (6-months apart) to estimate age-based norm scores and examine responsiveness of the
ORCA measure over time. With constant feedback from the SEG and the ETAC, we will provide an expanded
ORCA measure to the research field that can capture communication ability across a diverse range of NDDs, and
an endpoint framework for researchers to evaluate the efficacy of interventions using an outcome that is important to
families of children and adolescents with NDDs.

Public health relevance
PROJECT NARRATIVE In this collaborative project, we will use rigorous development methods to expand the Observer-Reported Communication Ability (ORCA) measure to 13 neurodevelopmental disorder populations. Additionally, we will provide age-based normative data from a US sample of typically developing children, evaluate other commonly used communication measures, and explore endpoint models to provide a comprehensive set of outcomes for capturing communication ability. Our ultimate goal is to provide investigators with a comprehensive set of tools to evaluate changes in communication ability in these vulnerable populations, which in turn, will help to facilitate crucial pediatric clinical trials.